EFFECT OF VISCOSITY ON GASTRIC EMPTYING OF LIGANDS AND SOLIDS ON AXIAL FORCES

To evaluate use of an axial force transducer to measure the effects of differing meal viscosities on axial forces generated postprandially.